The impact of inherited and modifiable risk factors on clonal hematopoiesis and age-related disease

ABSTRACT
The goal of this proposal is to improve our understanding of the factors that drive clonal hematopoiesis
(CH) evolution to prevent CH-related adverse outcomes and promote healthy aging. CH is common with
aging. Most mutations are present in a small proportion of hematopoietic stem cells (HSCs). Yet in some
individuals, the proportion of mutated HSCs will expand resulting in dysregulation of hematopoiesis and immune
cell function. CH is associated with several age-related diseases, including two leading causes of death and
disability among the elderly: cardiovascular disease (CVD) and Alzheimer's disease (AD). The mechanisms
driving CH evolution are largely undefined. This is due, in part, to a lack of longitudinal studies of CH alongside
comprehensive risk factor assessment. CH alters the balance of immune cell pro- and anti-inflammatory
signaling. This is thought to underlie many CH-disease associations. Pre-clinical models suggest that chronic
inflammation promotes CH fitness, but this has yet to be established in human studies. Chronic inflammation, as
driven by an unhealthy lifestyle, has also been shown to increase the risk of many age-related diseases.
Unhealthy lifestyle is prevalent throughout the United States and contributes to up to 60% of premature deaths.
There are conflicting results regarding the association between CH and an unhealthy lifestyle. This may be due
to measurement error driven by imprecise, one-time assessments of lifestyle risk factors. Longitudinal studies of
both CH and lifestyle risk factors over the life-course of an individual are needed. Here we seek to characterize
how inherited and lifestyle risk factors influence CH fitness and to identify the central pathways that determine
long-term CH evolutionary trajectories and disease progression. Through our preliminary work, we jointly
characterized CH and plasma proteomic profiles of 46,237 individuals in the UK Biobank (UKBB). We identified
79 proteins significantly associated with CH, the majority of which are known immune regulators. A subset of
these proteins also predicts risk of CVD and AD development. Our central hypothesis is that inherited, and
lifestyle risk factors impact CH evolution through immune dysregulation and that this in turn determines
the development of age-related outcomes. We will leverage existing data from large-scale biobanks alongside
comprehensive CH profiling in unique cohorts with repeated risk factor and biologic measurements. This includes
two prospective cohorts with >30 years of follow-up: 1) The Health Professionals Follow-up Study, with rich
assessment of lifestyle risk factors alongside centrally adjudicated CVD outcomes and 2) The Knight Alzheimer's
Disease Research Center studies with centrally adjudicated cognition and AD outcomes alongside serial CSF
sampling. The specific aims are: (1) determine the impact of lifestyle and inherited risk factors on CH
evolution, (2) determine the pathways that mediate CH evolution and (3) determine the pathways that
mediate the association between CH with CVD and AD.

Public health relevance
PROJECT NARRATIVE Clonal hematopoiesis (CH) is associated with several age-related diseases including cardiovascular disease (CVD) and Alzheimer's disease (AD) but the mechanisms driving CH progression and its impact on CVD and AD are largely undefined. Our central hypothesis is that inherited, and lifestyle risk factors impact CH evolution through immune dysregulation and that this, in turn, determines the development of disease. We will leverage existing data from large-scale biobanks alongside longitudinal CH and proteomic profiling in cohorts with rich phenotyping to determine (1) the impact of lifestyle and inherited risk factors on CH evolution, (2) the pathways that mediate CH evolution and (3) the pathways that mediate the association between CH with CVD and AD.